STIMULATION FOR CONTROL OF THE PARALYZED HAND IN THE C5/C6 SPINAL CORD INJURY

This study is to evaluate the performance of an implantable stimulator system designed to provide activation and control of the paralyzed upper extremity in high level spinal cord injury (tetraplegic) patients. The significance of this work is that functional neuromuscular stimulation may provide tetraplegic subjects with manipulative capabilities unavailable by alternative means.